Interplay between lipophagy and mitophagy in skeletal muscle aging

Summary: In this Administrative Supplement we are requesting support to repeat an major experiment described under the parent grant: “Interplay between lipophagy and mitophagy in skeletal muscle aging” (5R01AG020866). In this experiment, old and young (female and male C57BL/6J mice) will be used to isolate mononuclear cells which then will be analyzed by mass cytometry to explore, at the single cell level, changes in autophagy flux in each cell type. The original experiment could not be completed successfully due to logistical operations brought up by the Covid-19 pandemic.

Public health relevance
Narrative (From Parent Application): Loss of muscle mass and function that occurs in aging compromises physical performance, lifestyle, and recovery after injury for half of those in their late seventies or older. Autophagy (degradation of cellular components) appears to play a role in the changes observed in the muscle system. This application proposes the development of new methodologies to understand the cell types involved in those changes and define in those cells how the degradation of their cellular components is affected by aging.